Washington University Institute of Clinical and Translational Sciences (TL1)

Washington University has a robust research infrastructure, outstanding faculty mentors, well-developed clinical and translational research (CTR) training programs, and a large pool of excellent pre- and postdoctoral candidates. The objective of the TL1 program is to ignite an interest in becoming a CTR scientist and provide research experience, coursework, and career development opportunities to achieve this goal. We have successfully trained predoctoral MD, PhD and allied health doctoral students, as well as postdoctoral trainees interested in entrepreneurship, technology transfer, and intellectual property development. We aim to expand our program to add support for a mentored career development pathway for MD clinical fellows. We will introduce new innovative curricula in biomedical informatics, dissemination and implementation science, stakeholder collaboration, team science, ensuring proportionate access to health resources, and online initiatives. Simultaneously, we will develop new mentor training programs coordinated by the Clinical Research Training Center.

Public health relevance
The TL1 predoctoral and postdoctoral program develops a skilled workforce of clinical and translational researchers who can address complex health challenges. By providing rigorous training, mentorship, and interdisciplinary collaboration, it accelerates the translation of scientific discoveries into evidence-based practices, ultimately improving population health outcomes.